Innovative approaches to enhance regulatory immune cell function and renal transplant survival in nonhuman primates

OVERALL SUMMARY/ABSTRACT
In this P01, we will address the overall hypothesis that innovative regimens incorporating new agents and
cutting-edge technologies that selectively enhance regulatory immune cell function, will extend kidney allograft
survival and allow immunosuppressive drug withdrawal in rhesus macaques. The candidate regimens will be
tested in combination with progressive tapering and withdrawal of conventional immunosuppression (IS).
Our hypothesis in Project 1 is that graft survival can be extended and IS withdrawn in MHC-mismatched graft
recipients using innovative strategies that selectively enhance inherent dendritic cell (DC) tolerogenicity. These
approaches are 1) to target DCs in situ, either with an exciting, novel myeloid cell checkpoint agonist, or with
innovative, DC-directed nanobiologics and 2) to adoptively transfer autologous regulatory DCs (DCregs) pulsed
with donor-derived small extracellular vesicles (sEVs). Our Specific Aims are: Aim 1: To determine whether the
novel myeloid cell checkpoint agonist (anti-LILRB3 mAb) that promotes DC tolerogenicity and allotolerance in
mice, can extend graft survival/allow IS withdrawal; Aim 2: To ascertain whether selective targeting of DCs in
situ using novel, DC (DEC205)-directed nanobiologics can extend graft survival/allow IS withdrawal; Aim 3: To
assess whether infusion of autologous DCregs pulsed with donor-derived immunoregulatory sEVs can extend
graft survival/allow IS withdrawal.
Our hypothesis in Project 2 is that suppression of innate and adaptive immune mechanisms that would
otherwise destabilize induction of tolerance, will be conducive to DCreg and Treg function and consequent
prolongation of graft survival/IS withdrawal. We will use new, rhesus-specific mAbs to modulate inflammation,
attenuate donor-reactive Tmem and augment donor Ag alloreactive Treg (darTreg); we will also test next
generation donor Ag (Bw6)-specific chimeric Ag receptor (CAR)Tregs. Our Specific Aims are: Aim 1:To
mitigate post-Tx inflammatory responses and eliminate IS-resistant, donor-reactive pathogenic Tmem
through cytokine modulation using new, rhesus-specific neutralizing anti-IL-6 or IL-7R and IL-15R
blocking mAbs; Aim 2: To augment Ag-specific Treg through infusion of ex vivo-expanded, genetically-
engineered Bw6-specific CARTreg; Aim 3: To achieve durable, donor-alloreactive T cell regulation
through CARTreg infusion, combined with either cytokine modulation or in situ targeting of DC,
depending on the results of Project 2 Aim 1, and Project 1 Aim 1 and 2 results.
Both Projects will incorporate highly-interactive mechanistic studies and assess potential novel biomarkers.The
two Projects will be supported by an Administrative, Biostatistics and Bioinformatics Core (Core A), a
Transplant Pathology and Tissue Imaging Core (Core B) and a Nanotechnology Core (Core C) and will
utilize new agents from the NIAID NHP Reagent Resource. Our Program displays conceptual unity and strong
component synergy and incorporates special/unique features of the investigative team and environment.

Public health relevance
PROJECT NARRATIVE Regulatory immune cells,- both regulatory dendritic cells and regulatory T cells, are believed to play crucial and interactive roles in the promotion and maintenance of immunological tolerance. Innovative approaches and technologic advances that enhance the functions of these cells, while diminishing the functions of immune effector cells in a clinically-relevant nonhuman primate kidney transplant model, and elucidation of underlying mechanisms, as in this Research Program, may lead to improved long-term outcomes and tolerance induction in clinical organ transplantation.